Integrated Networks of Scholars in Global Health Research Training (INSIGHT)

PROJECT SUMMARY
In this supplement application, we are requesting funds to plan and coordinate a week-long orientation and
training workshop for the Fogarty LAUNCH Program. Planned for July 2025, this meeting will be held in-person
and brings together trainees from all seven consortia under the program's umbrella. Building upon more than a
decade of experience, this cornerstone activity prepares trainees across a range of subjects-both scientific and
applied in nature-to support their year of training and their future careers in global health research. It also
provides important networking opportunities with consortia faculty, international collaborators, NIH leaders,
alumni, and other trainees working in the same regions and/or in the same topical areas.

Public health relevance
NARRATIVE The Integrated Networks of Scholars in Global Health Research Training (INSIGHT) consortium formed between the University of Alabama at Birmingham, the Baylor College of Medicine, the University of Maryland Baltimore, and the University of Pittsburgh supports training for the next generation of global health scholars from the US and low- and middle-income countries (LMICs) through mentored research experiences at 24 established partner LM IC institutions across 19 countries in Africa, Asia, and Latin America and the Caribbean. Strong emphases are on a broad range of global health research areas, including combatting the global HIV epidemic and associated co-morbidities, emerging and re-emerging infectious diseases, non-communicable diseases, and mental health.